Evaluating Lung Cancer Screening Patterns and Outcomes in Diverse Populations and Settings

ABSTRACT
Lung cancer is the leading cause of cancer deaths in the United States, with higher rates of lung cancer among
Black versus White men, despite Black populations having lower smoking rates, smoking fewer cigarettes per
day, and being less likely to smoke heavily. Randomized trials demonstrated early detection of lung cancer
with annual low dose computed tomography reduces lung cancer mortality by 20-33% in high-risk populations.
In 2013 the US Preventive Services Task Force (USPSTF) recommended annual lung cancer screening (LCS)
in individuals ages 55-80 years who currently or former (quit within 15 years) smoked at least 30 pack-years.
Some studies suggested the 2013 USPSTF LCS eligibility criteria under selected women and Black individuals
who tend to smoke less intensely yet have increased risk of developing lung cancer. In 2021, the USPSTF
expanded their LCS recommendations to include individuals ages 50-80 years with at least a 20 pack-year
history, increasing the number eligible by more than 80% to 14.5 million U.S. adults. These expanded criteria
will result in higher relative increases in screening eligibility for women versus men and non-Hispanic Black
versus non-Hispanic White populations. Yet, the impact of the expanded 2021 USPSTF eligibility criteria on
screening practice and outcomes is unknown. The objective of this application is to understand how the
updated 2021 USPSTF LCS recommendations are implemented in practice and quantify the impact of the new
recommendations on the LCS care continuum from adherence to performance. Our central hypothesis is that
there will be race and sex-based differences in the benefits and harms of LCS among newly eligible individuals
(e.g., ages 50-54 years or smoking 20-29 P-Y) because of heterogeneity in the baseline risk of developing lung
cancer. Guided by strong preliminary data, the hypothesis will be tested by pursuing the following specific
aims: 1) Evaluate patients’ and clinicians' attitudes, knowledge, and experiences with the expanded 2021
USPSTF LCS recommendations; 2) Determine the impact of the 2013 vs. 2021 USPSTF LCS eligibility criteria
across the screening care continuum in terms of (a) baseline lung cancer risk in the population screened, (b)
adherence to annual LCS, and (c) receipt of recommended care following an abnormal LCS result; and 3)
Compare the performance of LDCT LCS in individuals screened per the USPSTF 2013 criteria versus the 2021
newly eligible criteria. The study is innovative in combining survey and quantitative methods in a large, diverse,
community-based population to evaluate the impact of the 2021 USPSTF LCS recommendations on LCS care
patterns and outcomes. The proposed research is significant because it will quantify the experiences of LCS in
the 14.5 million individuals now eligible for screening. The findings are expected to advance and expand our
understanding of LCS in diverse populations and settings which will enable clinicians to deliver more evidence
based, high-quality LCS care.

Public health relevance
PROJECT NARRATIVE The proposed study will generate population-based data on the effectiveness of lung cancer screening with low dose computed tomography. These results have the potential to inform patient and clinician shared decision- making conversations and future US Preventive Services Task Force evidence reviews. As the number of patients screened for lung cancer increases due to expanded eligibility criteria, this research is timely and responsive to the National Cancer Institute’s goal to support research in cancer control that will help inform guideline development and policy decisions.